Understanding the Origins of Early COPD

ABSTRACT
The fundamental gap existing in understanding the origins of Chronic Obstructive Pulmonary Disease
(COPD) is centrally responsible for the lack of any disease-modifying therapies for this highly prevalent and
lethal disease. Developing and testing such therapies will require defining the biologic process occurring in the
human lung that induce small airway abnormality (SAA), the earliest COPD pathology, and which cause
transition from potentially reversible SAA to irreversible emphysema or airway remodeling. Our long term goal
is to arrest COPD progression by understanding its earliest stages. Our Central Hypotheses are: SAA
(detectable by chest imaging) identifies susceptible younger smokers at heightened risk of anatomic disease
progression. SAA results, in part, from distinctive types of auto-aggressive host immune reactions (detectable
by measuring epithelial gene signatures and immune cell function) and from altered airway surface liquid
(detectable by analyzing airway mucin). These processes collectively lead to SAA detectable by a novel high-
resolution chest computed tomography (HRCT) metric (PRMfSAD) we have developed. The knowledge gained
in this project will allow us to identify individuals with disease progression noninvasively, while also defining
pathophysiological mechanism(s) that can be therapeutically targeted. In this project we will leverage the
infrastructure of SPIROMICS, an NHLBI funded COPD program, to recruit a new cohort of individuals aged 35-
50 years, a group which are not represented in the current cohort. Subjects will be analyzed at clinical visits at
enrollment and after three years of follow-up. At each visit, they will undergo clinical data collection, post-
bronchodilator spirometry, HRCT, induced sputum, and exhaled breath condensate. One hundred subjects will
also undergo a single research bronchoscopy. In Aim 1, we will determine the relationship between HRCT-
defined SAA and disease progression in early COPD. Specifically we will define the relationship between
baseline PRMfSAD and development of radiographic disease progression to PRM defined emphysema over
three years. In Aim 2 we will explore the biological basis of SAA in early COPD by analysis of lung-derived
biomarkers. To achieve this we will collect biospecimens by bronchoalveolar lavage (BAL), and from
segmental & distal airways. We will correlate baseline PRMfSAD with an IL-17 gene signatures in airway
epithelium. Secondary analyses will explore correlations of baseline PRMfSAD with the activation states and
functional capacity of BAL leukocytes, as well as with total airway mucin concentration. In Aim 3 we will
determine whether sputum can serve as a non-invasive biomarker of early COPD. Specifically we will: a)
correlate baseline sputum total mucin concentration with baseline SAA; and, (b) correlate baseline sputum total
mucin concentration and its change over 3 years with progression of HRCT abnormalities. This approach
enables us to link HRCT and pathologic abnormality to define potentially targetable mechanisms laying the
foundation for developing disease-modifying therapies.

Public health relevance
There is a fundamental gap in understanding the early origins of Chronic Obstructive Pulmonary Disease. Our long term goal is to arrest COPD progression by under- standing its earliest stages. We will recruit a new cohort of younger at-risk individuals to link chest imaging and pathologic abnormality with longitudinal disease progression and thus define potentially targetable mechanisms laying the foundation for developing disease-modifying therapies.